DIRECT ELECTRON DETECTOR

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Direct electron detection (DDD) sensor images high-energy electrons directly. By avoiding the electron-to-light conversion process of a scintillator, the DDD achieves unprecedented sensitivity and resolution. The DE-12 Camera System developed by Direct Electron in San Diego is based on a 12 Mpixel DDD sensor featuring a 3K by 4K array of 6 micron pixels. It offers very high signal-to-noise ratio (SNR) for primary electrons (>30:1) enables single electron counting.It also has a fast readout rate with 25 msec per 12 Megapixel frame. It can be placed in the camera chamber in any of our JEOL electron microscopes (JEM3200FSC and JEM2200FSC). We perform a resolution test with a demo unit from the company.